Project 2: Epigenetic, Behavioral, and Physiological Outcomes in a Mouse ART Model

Abstract
Assisted Reproductive Technologies (ART) are invaluable for the increasing number individuals who require
interventions to treat their infertility. Nevertheless, ART-conceived children are at increased risk for loss-of-
imprinting disorders, e.g., Angelman Syndrome, resulting from epigenetic errors, as well as placental disorders,
abnormal growth, congenital malformations, and postnatal cardiac and metabolic disorders. These problems
likely arise because ART procedures take place when the preimplantation embryo is being epigenetically
reprogrammed. Because it is difficult to conduct studies using human embryos, a mouse model system, which
anticipated risks associated with ART, will be used to assess the effect of ART interventions on placental
morphology, imprinted gene regulation, growth, physiological phenotypes of the offspring, and epigenetic gene
regulation, including DNA methylation and chromatin structure genome-wide. Oocyte vitrification is being
increasingly used for donors as well as older women to prolong their fertility. Little is known, however, about its
effects on embryo development and resulting offspring. Specific Aim 1 will use our mouse model to assess
whether oocyte vitrification in the context of IVF exerts additional dysregulation of epigenetic profiles, placental
morphology and fetal sufficiency. Moreover, although the majority offspring conceived using ART are healthy, a
small percent have abnormal imprinted gene regulation and outlier DNA methylation phenotypes. Specific Aim
2 will characterize phenotypes associated with mice that have extremely abnormal DNA methylation at ICRs to
determine if they too exhibit adverse metabolic and epigenetic outcomes as they age. Finally, very little work
has addressed the mechanism(s) of adverse epigenetic patterns in ART conceptuses. Embryo culture
disproportionately contributes to adverse phenotypes of IVF offspring, i.e., abnormal morphological and
epigenetic patterns. We hypothesize that elevated oxygen concentration during embryo culture contributes to
this phenotype via dysregulation of oxygen-sensitive proteins. Specific Aim 3 will examine the role of O2
environment in mediating adverse placental and embryonic outcomes in ART by adjusting oxygen
concentration and assaying gestational outcomes. Additionally, to address the mechanism of elevated O2 in
the extensive epigenetic dysregulation we observe in cultured embryos, we will focus on the histone
demethylases, KDM6A (H3K27me2/3 demethylase) and KDM5A (H3K4me2/3 demethylase), whose enzymatic
activity depends on O2 concentration, and determine changes in the global chromatin landscape of these two
histone marks in blastocysts as a function of O2 concentration. Results of these experiments will provide
information regarding the linkage between epigenetic changes and health of offspring conceived by ART.
Together with results from other projects in this P50, our findings may identify experimental modifications to
ART procedures that will improve offspring outcomes.